The role of cell surface glycosaminoglycans (GAGs) in PTHrP bias signaling

Project Summary/Abstract
The parathyroid hormone (PTH)-related protein (PTHrP) is essential for mammary gland development, placental
calcium ion transport, tooth eruption, bone formation and remodeling, and causes hypercalcemia in patients with
malignancy. Our current understanding of how endogenous PTHrP (PTHrP1-141) transduces signals through the
PTH type 1 receptor (PTHR), a Class B G-protein coupled receptor (GPCR), is largely based on studies done
with its N-terminal fragment (PTHrP1-36). However, pilot studies revealed that signaling properties of endogenous
PTHrP are distinct from its N-terminal fragment and dependent on heparin/heparan sulfate, a glycosaminoglycan
(GAG). The role of extracellular matrix components, such as GAGs, in PTHR signaling and trafficking has largely
been ignored. Thus, the goal of this proposal is to determine the molecular and cellular mechanisms by which
heparan sulfate controls PTHrP signaling via PTHR. We hypothesize that the interaction between
heparin/heparan sulfate and PTHrP maintains local concentrations of the hormone at the cell surface, which
enhances the rate of receptor binding and ligand residence time on PTHR, and consequently contributes to
location biased signaling mediated by PTHrP. The first Aim will address this hypothesis by characterizing the
binding properties of PTHrP and heparin/heparan sulfate interaction using biophysical approaches. The second
Aim will employ single-cell and single-molecule optical imaging approaches to determine the functional role of
heparin/heparan sulfate and the mechanism by which PTHrP signals via PTHR. The findings of this proposal will
provide insight into the ligand biased signaling mechanism of PTHR, and contribute to the overall understanding
of GPCR signaling beyond the field of pharmacology.

Public health relevance
Project Narrative The parathyroid hormone (PTH)-related protein (PTHrP) is a key paracrine and autocrine regulator of bone formation and remodeling, tooth eruption, mammary gland development, placental calcium ion transport, and the main cause of hypercalcemia and osteolysis in patients with malignancy. The proposed research will investigate a novel component, heparin/heparan sulfate, in PTHrP signaling via its PTH type 1 receptor (PTHR). The findings will advance our fundamental understanding of the key cellular and molecular mechanisms underlying PTHrP signaling that are essential for the development of new therapies targeting PTHrP associated diseases.